EFFECT OF SHORT TERM WEIGHT LOSS ON INSULIN SENSITIVITY IN CHILDHOOD OBESITY

Exploration of the relationships between insulin sensitivity, hypertension, physical fitness, body composition and weight reduction in childhood obesity.